Southern Hemisphere Influenza and Vaccine Effectiveness Research and Surveillance

Influenza and Other Respiratory Diseases in Southern Hemisphere The NCIRD Influenza Division (ID) is cooperating with the WHO Collaborating Center for Studies on the Ecology of Influenza in Animals and Birds, and with New Zealand public health laboratories and Universities to conduct a five year study in the southern hemisphere on influenza and other respiratory diseases; their burden, epidemiology, transmission, risk factors, and the effectiveness of vaccination. The influenza season in New Zealand occurs during the northern hemisphere summer, and therefore can provide critical information on the epidemiology, burden, strains and effectiveness of prevention measures of influenza and other respiratory pathogens at a time when study sites in the northern hemisphere cannot. In addition, understanding the epidemiology of influenza and the effectiveness of annual vaccines in the southern hemisphere will provide needed data for influenza control strategies in other parts of the world. The first primary objective of the study is to estimate and assess the incidence rate, prevalence and clinical spectrum, pathogenesis and outcomes of severe pneumonia and severe acute respiratory infection (SARI) caused by types and subtypes of influenza viruses and other respiratory pathogens and differences of these parameters among population sub-groups at possibly increased risk for disease. The second primary objective is to assess the annual effectiveness of influenza vaccines in preventing laboratory confirmed influenza, through observational studies of existing programs including differential effectiveness among subpopulations. In addition to the primary objectives, additional studies to be conducted on interaction between influenza infection and other infections, etiologies and causes of respiratory mortality, non-severe illness due to influenza and other respiratory pathogens, serological studies of annual infection risk, impact of various risk factors for influenza infection or severe disease, immune response to influenza, healthcare and societal economic burden of influenza disease, and assessment of cost-effectiveness of influenza vaccination. These assessments will be made for the Auckland population in New Zealand through the establishment of enhanced real-time surveillance in sentinel practices and hospitals.

Public health relevance
Project narrative Combating seasonal and pandemic influenza relies on being able to accurately identify the disease in all its forms from mild infection though to severe disease causing hospitalization and death. We also need to understand how our immune systems respond to this virus, monitor the effectiveness of our influenza vaccines, and know how we can prevent disease through improvements to housing, nutrition, personal behavior and other factors. This project will answer all of these questions in a southern hemisphere setting (New Zealand) which has high quality public health surveillance systems and a proven track record for early warning about pandemic influenza viruses. __SpecificAimsTextDelimiter__ Specific Aim: New Zealand (NZ) is a temperate southern hemisphere country that lies entirely below the Tropic of Capricorn. Its influenza season predominantly occurs during the northern hemisphere summer (June to September) and what is observed often predicts the subsequent northern hemisphere experience. A number of factors combine to make NZ an unmatched location for population based research, including its predominantly public funded healthcare system and associated health information systems. All New Zealanders have a unique identifier - the National Health Index number - that allows tracking of individual healthcare utilization over time and linkage to multiple data sources (e.g. notifiable diseases, primary care, hospitalization, mortality, pharmaceuticals and geographically referenced data). Additionally, patients are registered with primary care providers who maintain highly computerized records with detailed demographic, risk factor and immunization status information. The NZ population is extremely well characterized according to demographic structure, particularly by ethnicity and socioeconomic group. Indigenous Maori and Pacific immigrant populations (collectively 20% of the population) are vulnerable to influenza and other respiratory infections and will be of particular interest in this proposed research. Using this unique infrastructure, we propose expanding NZ's existing influenza surveillance systems by establishing two (hospital-based and community-based) prospective surveillance systems in Auckland (population 1.3 million). These systems will provide real-time strategic information to NZ and to northern hemisphere countries during inter-pandemic and pandemic periods. In addition, these two surveillance systems will provide data and specimens for three main streams of research: 1. Comprehensive description of the epidemiology and etiology of influenza and related respiratory infections (and their potential interactions) for: (a) severe disease (hospitalized SARI cases, ICU admissions and deaths); (b) non-severe disease (community ILI consultation cases); and (c) infection (seroconversion). These data will give us a full description of the 'pyramid' of disease from infection to severe illness and death in the total population and vulnerable subgroups and the related economic burden. Results will guide improved methods for disease surveillance in multiple settings and assist early detection of epidemics and pandemics, and optimize clinical case management and laboratory diagnosis. 2. Robust estimation of the protective effect of seasonal influenza vaccine in the prevention of hospitalized and community influenza using test negative case-control methods as well as a case-cohort design. In addition, the same methods will be applied to investigate differential vaccine effectiveness among subpopulations (e.g. elderly and those with co-morbidities). Interconnecting the epidemiological and immune studies in severe and non-severe disease cases and high risk subgroups will facilitate our understanding of host immune responses and guide better vaccine design and immune diagnostic markers. Results will be useful for improving population and subgroup targeted vaccine strategies. 3. A multifaceted understanding of influenza risk that considers organism, host and environmental factors and opportunities for intervention. This comprehensive approach will include detailed consideration of the independent contributions of host ethnicity, socioeconomic position, chronic illness status, body mass index (BMI), vitamin D status, household environment exposures, humoral and cellular immune response and infecting virus. Results will guide non-pharmaceutical interventions and preventive measures. Our program includes a set of innovative studies that are interconnected to serve multiple objectives and hence maximize efficiency and study power. Combined with NZ's healthcare structures, it provides a unique base to answer many unresolved questions about influenza. Such questions include understanding the 'true' contribution of influenza to serious respiratory disease and the independent contributions of chronic disease, raised BMI, ethnicity and socioeconomic deprivation to disease risk. Innovative epidemiological methods will be used to measure vaccine effectiveness in the general population and subgroups in relation to vaccine formulation and variations in the virus over time. Novel methods will be used to assess influenza-specific humoral and cellular immune responses among well-characterized individuals with varying disease severity. And new molecular strategies will be employed to assist the timely identification of known and unknown etiologic organisms causing respiratory disease. As the applicant, ESR has collaborated with NZ's two leading research universities (University of Otago and University of Auckland), and the Auckland District Health Board to assemble a multi-disciplinary and multi- center team consisting of leading influenza researchers in NZ and abroad. ESR hosts the WHO National Influenza Centre and Health Intelligence Team working on influenza epidemiological and virologic surveillance. The research team submitting this proposal has been carefully selected to have the skills, knowledge and experience to address all of the research objectives. Most importantly this research team has successfully collaborated on influenza-related research for several years and has published numerous joint papers on all facets of both seasonal and pandemic influenza A(H1N1). Together with its geographical location, health care and data management systems, and available human resources, NZ is in a unique position to explore the nature of winter-time respiratory diseases and make a major contribution to global public health in this area.